EFFECTS OF PERCEPTIONS ON TASTE PREFERENCES

This study is designed to examine several possible mechanisms linking stress to distinct eating patterns. One is whether taste preferences change as result of being in a stressful or non-stressful environment and whether taste preferences under these two conditions can be predicted from a person's self-reported tendency to eat more or less when stressed.